Prediction of Alcohol Use Disorder and PTSD After Trauma in Adolescents

PROJECT SUMMARY
Acute trauma, defined by the DSM-5 criterion A for the diagnosis of post-traumatic stress disorder (PTSD) as
exposure to actual or threatened death, serious injury or sexual violence, is associated with an increase in the
development of both Alcohol Use Disorder (AUD) and PTSD. It is well established that patients with PTSD
have a markedly increased risk for AUD. Furthermore, understanding risk for AUD during development,
particularly in adolescents is critical, as early onset drinking is one of the highest risk factors for lifetime alcohol
addiction. This current proposal seeks to further explore the relationship of AUD and PTSD in adolescents
exposed to acute trauma by focusing on biological predictors of AUD and/or PTSD development. In brief, 500
adolescents will be studied in the immediate aftermath of trauma in emergency departments, hospital clinics or
psychiatric settings in Austin, Texas (Dell Children’s Medical Center) and Galveston, Texas (University of
Texas Medical Branch (UTMB) affiliated hospitals). Using emerging statistical techniques and machine
learning-based analytics, we will identify predictive: 1. Genomic and epigenomic, 2. Inflammatory, and 3.
Psychophysiological biomarkers of risk for AUD and PTSD. Although several risk factors have been identified
in adults for the development of these two disorders, relatively little data is available in adolescents. Family and
twin studies have provided estimates of genetic risk for AUD and PTSD of 50% and 30-40%, respectively. We
will utilize the latest AUD and PTSD polygenic risk factor scores for these disorders, together with epigenomic
analysis. Previous work has implicated alterations in inflammatory response in both AUD and PTSD and we
will assess this in the immediate aftermath of the trauma. Finally, measures of autonomic nervous system
(including skin conductance response [SCR], heart rate and heart rate variability [HRV] via electrocardiography
[ECG]) and central nervous system (acoustic startle response assessed via electromyography [EMG])
reactivity will be assessed immediately after post-trauma medical clearance. Using state of the art statistical
modeling, we will identify biological predictors of AUD and PTSD and their interrelationship. These data will be
used to develop novel tools to predict which adolescents exposed to trauma will likely develop AUD and/or
PTSD, allowing for early intervention at this critical time in development.

Public health relevance
PROJECT NARRATIVE It is well established that individuals exposed to trauma are at increased risk for both Alcohol Use Disorder (AUD) and post-traumatic stress disorder (PTSD); moreover, there is a high rate of comorbidity of these two disorders. The vast majority of this research has been conducted in adults. In this proposal, we will identify biological predictors of AUD and/or PTSD including genomics, epigenetics, inflammation and psychophysiology in the immediate aftermath of trauma in order to determine which adolescents are at risk to develop these devastating disorders.